FASEB's "The Lung Epithelium Conference: In Health and Disease"

Project Summary The 2020 FASEB Science Research Conference, The Lung Epithelium in Health and Disease, is the 11th biannual conference in this area, bringing together developmental, cell and molecular biologists, geneticists, physiologists, clinicians and translational researchers with a primary interest in lung epithelial biology. The topics selected represent the cutting-edge of lung research and the program is planned to disseminate new findings with translational potential to accelerate progress toward novel therapies for lung disease. Topics include (1) molecular mechanisms of lung epithelial development, repair/regeneration, and plasticity (2) common and unique pathways of intra-epithelial communications in lung physiology and diseases, (3) interactions between lung epithelium and distinct immune cells (4) cutting-edge technologies including single-cell analysis approaches and ex-vivo models for investigating lung epithelial biology . In addition to the unique collection of research topics, this meeting provides a platform for new speakers, early stage investigators, and trainees. Twenty-two of 33 speakers (67%) have not spoken at this conference in the last four years, and thirteen of the 33 speakers (40%) are women, as well as half of the session chairs. Sixteen short-talk sessions are designated for trainees or new investigators. Specific efforts are being made to encourage participation by underrepresent minorities in the field. In addition to talks, there are 3 poster sessions and 4 “Meet-the-Experts” sessions to facilitate scientific and social interactions between all participants. By bringing the best of the lung epithelium research community together, the overall goal of this conference is to push the field forward towards innovative directions for basic research and novel therapeutics for important lung diseases, including asthma, chronic obstructive pulmonary disease, pulmonary fibrosis, and bronchopulmonary dysplasia.

Public health relevance
Project Narrative The 2020 FASEB Science Research Conference, “The Lung Epithelium in Health and Disease,” is the primary forum for discussion of cutting-edge research into lung epithelial biology. The objective of the conference is to stimulate meaningful discussion, facilitate collaboration and establish new research directions and priorities. This meeting brings together basic scientists, translational researchers and clinician investigators to discuss state-of-the-art approaches to understand the molecular mechanisms which underlie a broad range of respiratory diseases such as asthma, bronchopulmonary dysplasia, chronic obstructive pulmonary disease, idiopathic pulmonary fibrosis, and others. Another primary objective of this conference is to serve as a major forum for early stage investigators and trainees to present their work, facilitating development of the “next generation” of lung epithelial biologists. By linking the pathobiology of these disorders to normal lung development and lung cell differentiation, central themes will be identified to provide a mechanistic understanding of these diseases. By bringing together a group of scientific leaders with diverse expertise, this conference will facilitate unique cross-disciplinary insights that will accelerate progress toward the development of novel therapeutic approaches for a variety of lung diseases.